MPS Models Development and Validation Core

ABSTRACT MPS MODELS DEVELOPMENT AND VALIDATION CORE
With the advancement of robust differentiation protocols and the generation of large cohorts of iPSC lines, the
field now stands ready to utilize iPSC technology for the purpose of disentangling person-specific or subtype-
specific processes driving risk and resilience for Alzheimer’s disease. To this end, we have recently generated a
cohort of iPSC lines from over 100 individuals of diverse ancestry from the ROS and MAP cohorts of aging.
These cohorts are deeply phenotyped with acquisition of longitudinal cognitive data, quantitative
neuropathological measurements, and multi-omics data acquired from brain tissue and plasma. The goal of the
MPS Models Development and Validation Core is to develop robust and reproducible human cellular
experimental systems for testing therapeutic strategies across diverse genetic backgrounds. Three experimental
systems that be utilized are 1) a reductionist 2D co-culture system of neurons, astrocytes, and microglia; 2) a
Brain-Chip system that incorporates neurons, astrocytes, microglia, pericytes, and endothelial cells that form a
layered blood-brain-barrier (BBB) on a two-chambered microfluidic device; and 3) a 3D engineered organoid
system, the multi-cellular integrated Brain (MiBrain), which incorporates up to seven different cell types. We
employ these three systems which each have unique advantages and disadvantages with the understanding
that different therapeutic strategies may require different experimental setups in order to accurately and reliably
relay target engagement, efficacy, and safety. The activities of this core fall under four specific aims. First, this
core will generate key foundational data for each experimental system using both multi-omic, unbiased
approaches and directed biomarker measurements to define the molecular signatures of brain cells across
diverse genetic backgrounds. These measurements will be coupled to functional measurements of biological
domain disruption. In aims 2-4, we will develop preclinical efficacy assays for testing of interventions for AD that
target three different processes: 1) Ab levels, 2) synaptic vulnerability, and 3) microglial dysfunction. We will
define the molecular signatures of human brain cells in response to six interventions that span these three
biological domains. Data generated under this core’s activities will be analyzed within the Biostatics and
Computational Biology Core, where it will be integrated with omics and biomarker data from human natural
aging studies as well as biomarker data from individuals receiving some of the same interventions. Protocols for
the cellular models and top performing assays established here will be shared with and scaled within the
Preclinical Efficacy and Safety Core, to allow for the testing of interventions across >100 genetic backgrounds
using biomarker readouts of responsiveness established under the MPS Core’s activities. The Administrative
and Data Management Core will provide oversight and guidance on this core’s activities, and will establish
efficient pipelines for distribution of data, protocols and cell models.